Enhancing Speed and Accuracy of Motor Evoked Potential Recruitment Curve Analysis Using Hierarchical Bayesian Modeling

SUMMARY
Recording motor evoked potentials (MEPs) in response to electrical and electromagnetic stimulation of the
sensorimotor system is an important technique to probe the nervous system. It allows for the assessment of
state, measuring the extent of injury, tracking recovery, and measuring the eﬃcacy of interventions, including
neuromodulation. The relationship between stimulation intensity and MEP size is captured by the recruitment
curve (RC), deﬁned by several parameters, notably the threshold intensity that triggers an MEP.
Current RC characterization techniques, which are either oﬄine or online, have distinct limitations. Oﬄine
methods, applied post-data acquisition, rely on numerical optimization to ﬁt RCs but often lack precision in
parameter estimation. Online methods, while optimizing sampling during experiments and eﬃciently
calculating threshold parameters in an individual muscle, have a limited scope and miss critical estimates,
such as oﬀ-target changes in excitability, which could be crucial in neuromodulation studies.
To address these challenges, we have developed a Python library, hbMEP, which integrates a novel RC within
a hierarchical Bayesian framework for oﬄine use, post data acquisition. Our results indicate that hbMEP
provides more accurate parameter estimates and increases statistical power over conventional methods.
To further capitalize on the advantages of our approach, in Aim 1, we plan to extend hbMEP with an online
Bayesian recruitment curve estimation algorithm. While maintaining the robustness and accuracy of our oﬄine
approach, this enhancement leverages hbMEP's generative capabilities to optimize sample selection, targeting
multiple muscles, parameters or the entire curve—capabilities beyond currently used algorithms. The second
aim involves a comprehensive validation of the extended hbMEP's capabilities through physical experiments.
We will validate both the technical and scientiﬁc merits of our methods by comparing them against currently
dominant algorithms such as ML-PEST. Concurrently, we will further extend hbMEP with a user-interface.
This will simplify advanced analyses, making them usable by a broader range of users and minimizing the
necessity for extensive pre-processing. We will validate usability by aggregating study level metrics such as the
System Usability Scale (SUS) and task level metrics under the guidance of Columbia’s Usability Center.
Successful completion of this proposal will impact how neurophysiology experiments are conducted, oﬀering
more accurate insights into a stimulated nervous system’s responses and a more generalizable approach to test
hypotheses regarding the neurophysiological eﬀects of an intervention. This hierarchical Bayesian approach
will signiﬁcantly lower experimental burden by reducing the number of participants and stimuli required
while maintaining accuracy and simultaneously increasing the number of muscles across which these insights
are obtained. Moreover, our approach sets the stage for future closed-loop experimental designs and novel
state-dependent analyses, thereby contributing substantially to the ﬁeld.

Public health relevance
NARRATIVE Transcranial magnetic stimulation and epidural spinal cord stimulation play a crucial role in advancing our understanding and manipulation of neural activity for both research and therapeutic purposes. Our innovative hierarchical Bayesian approach to modeling recruitment curves promises to signiﬁcantly improve the eﬃciency and precision of experiments that use electrical or electromagnetic stimulation techniques, reducing the experimental burden for participants as well as experimenters. By enhancing experimental eﬃciency in multiple experimental se ings and techniques, this research directly contributes to accelerating the translation of scientiﬁc discoveries into clinical applications.